The Fibrosis-Immunity Interface in Corneal Transplantation

PROJECT SUMMARY/ABSTRACT
Corneal transplantation is the most commonly performed type of solid-tissue transplantation in the world and T
cell-mediated alloimmune rejection is the most common cause of corneal transplant failure. We have recently
demonstrated that immune rejection leads to myofibroblast formation and the novel finding that myofibroblasts
are capable of suppressing T cell alloimmunity. This preliminary data has laid the foundation for the present
comprehensive research program in which we investigate the mechanisms by which myofibroblasts regulate
effector T cell function and trafficking in corneal transplantation. In Specific Aim 1 we will define the precise
mechanisms by which myofibroblasts regulate alloreactive effector T cell function. To complete this Aim, we
will utilize a corneal myofibroblast and T cell co-culture system to identify and modulate candidate factors
regulating T cell activation, proliferation, function and survival. We will then use a murine model of corneal
transplantation to demonstrate the critical role of myofibroblast-derived factors in suppressing T cell
alloimmunity, thereby improving corneal transplant survival in vivo. In Specific Aim 2, we will define the precise
mechanisms by which myofibroblasts regulate alloreactive effector T cell trafficking to the transplanted corneal
graft. To complete this Aim, we will utilize in vitro migration assays to determine how myofibroblasts regulate T
cell chemotaxis and a corneal myofibroblast and vascular endothelial cell co-culture system to define how
myofibroblasts regulate T cell extravasation. We will then modulate select myofibroblast-derived factors in our
in vivo model of corneal transplantation to demonstrate their critical role in suppressing T cell infiltration of the
transplanted corneal graft and graft rejection. The overarching goal of this research program is to investigate
the relationship between myofibroblasts and alloreactive T cells in corneal transplantation, providing
fundamental insights in a previously unexplored area. Ultimately, through this work we hope to leverage the
immunosuppressive properties of myofibroblasts to identify and develop novel therapeutic strategies for the
prevention and/or treatment of T cell-mediated immune rejection in corneal transplantation and other forms of
solid-tissue organ transplantation.

Public health relevance
PROJECT NARRATIVE Corneal transplantation is the most commonly performed type of solid-tissue transplantation in the world and immune rejection caused by T cells is the most common reason for a corneal transplant to fail. We have recently shown that immune rejection leads to the formation of myofibroblasts and that myofibroblasts are capable of controlling T cells. In this research program we investigate how myofibroblasts control T cell function and how myofibroblasts control the migration of T cells to the transplanted cornea in order to identify new strategies for preventing and treating immune rejection in organ transplantation.